EOI:: IMPLEMENTING THE PRESIDENT'S 'DEPARTMENT OF GOVERNMENT EFFICIENCY' COST EFFICIENCY INITIATIVE (MARCH 19, 2025) ::EOI BILATERAL MODIFICATION TO DESCOPE WORK FOR NATIONAL HEART, LUNG, AND BLOOD

Provide subject matter expert assessments of NHLBI’s Assessment and Authorization and IT Controls processes confirming NHLBI’s Risk Management Framework approach is applied, employing National Institute of Standards and Technology standards. Identify system-specific gaps, and program-wide deficiencies, issuing corrective action plans to inform programmatic improvements based on trends and findings across systems.